Nanodelivery of FP polymers to improve treatment of metastatic colorectal cancer

PROJECT SUMMARY
Metastatic colorectal cancer (mCRC) remains highly lethal despite decades of optimizing 5-fluorouracil (5-FU)-
based combination chemotherapy regimens that are central to treatment. The causes of treatment failure with
5-FU-based regimens include decreased metabolism to FdUMP, the primary active metabolite, and
overexpression of thymidylate synthase (TS), the molecular target of FdUMP. To improve outcomes and
overcome resistance we have developed a nanoscale FP polymer, CF10, that is comprised of FdUMP monomers
linked in a single-stranded DNA backbone that releases FdUMP in a single step. CF10 displays markedly
improved anti-tumor activity with low systemic toxicity relative to 5-FU and is a candidate for clinical translation.
We hypothesize that nanoformulation of CF10 to increase plasma retention and actively target malignant tissue
will improve anti-tumor activity and specificity. Lipid nanoparticle (LNP) formulation has proven to be a robust
delivery strategy for multiple nucleic acid drugs, and in collaboration with NanoVation Therapeutics (NTx) in Aim
1 we will test two CF10:LNP formulations designed to differentially target CF10 to liver and more broadly to target
metastatic tissue while protecting CF10 from degradation in plasma. In Aim 2, we will investigate PEGylation of
CF10 together with active targeting to tumor tissue through conjugation with a cyclic RGD peptide that targets
integrin V3 expressed specifically in malignant tissue. We will test our novel nanomaterials for improved anti-
metastatic activity using: (i) a novel genetically engineered mouse model, iKAP, that forms tumors specifically in
the colon with metastatic progression to the liver and lung; and (ii) a rat model of established colorectal liver
metastases (CRLMs). Pharmacokinetic profiling (PK) will be evaluated using LC/MS/MS. In Aim 3, we will
develop a 3rd generation FP polymer that includes 5-ethynyl-2’-deoxyuridine (EdU), a thymidine analog that is
cytotoxic through complementary mechanisms to FdU. We will use the optimal LNP formulation and PEGylation
strategies determined for CF10 in Aims 1 and 2 to develop a highly novel nanomaterial with exceptional potential
for improved treatment of mCRC.

Public health relevance
PROJECT NARRATIVE This R01 proposal will develop novel nanoformulations of CF10, the first DNA-based fluoropyrimidine (FP) polymer. CF10 displays improved anti-cancer activity relative to standard of care 5-FU in pre-clinical colon cancer models and an improved toxicity profile. Lipid nanoparticle (LNP) formulation and conjugation with polyethylene glycol (PEG) polymers will be implemented to improve CF10’s pharmacological properties. Further, our nanomaterials will be targeted specifically to tumor tissue using a tripeptide motif, RGD, recognized only by malignant cells. We prepare for the first time FP polymers including EdU, a nucleotide analog with complementary cytotoxicity to CF10, and implement the most effective nanoformulation to deliver the most potent FP polymer. Our project will produce a novel nanomaterial with exceptional antitumor activity for clinical development.